Babson Life Sciences Entrepreneurial Product Development Immersion for New Technologies and Solutions (Babson L-SPRINT) Program

PROJECT SUMMARY
Babson Life Sciences Entrepreneurial Product Development Immersion for New
Technologies and Solutions (Babson L-SPRINT) Program
Commercialized innovations and new ventures that address certain conditions, including
ventures that address the causes, consequences, and treatment of substance use disorders
(SUDs) to improve individual and public health, are still underrepresented amongst recent
startups. Commercialization and technology-based start-ups can be challenging in an academic
environment due to varying reward structures, organizational structures and organizational
cultures. Many promising scientists are reluctant to pursue intellectual property (IP) protection
and investigate commercialization opportunities, even for unique research findings, due to a lack
of understanding of the mechanics towards productizing and commercialization.
To address these misperceptions and challenges while amplifying the potential impact that
academic scientists can make to address SUDs, the Babson Life Sciences Entrepreneurial
Product Development Immersion for New Technologies and Solutions (Babson L-SPRINT)
Program will reach scientists interested in product development and commercialization as well as
to train participants in entrepreneurial thinking that can also increase decision making, improve
their organizations and labs from within, especially since product development in the biomedical
industry is highly uncertain. The Babson L-SPRINT Program includes two aims:
Aim 1: Curriculum Development--The Babson L-SPRINT program will develop a specialized
curriculum highlighting Babson’s signature Entrepreneurial Thought & Action ® offering coupled
with customized healthcare and biomedical entrepreneurship content on addressing market
segmentation and uncertainty, commercializing emerging technologies, scaling for growth, and
biomedical community experiences. The program will use live cases, panels, and other
experiential learning techniques.
Aim 2: Courses for Skills Development--We will also develop a recruitment and outreach
strategy using an innovative omnichannel approach including direct marketing utilizing email,
relevant conferences, and via NIH NIDA newsletters and other media as available.

Public health relevance
PROJECT NARRATIVE Babson Life Sciences Entrepreneurial Product Development Immersion for New Technologies and Solutions (Babson L-SPRINT) Program Biomedical entrepreneurship and health-related entrepreneurship at large is recognized as central to improving health outcomes, economic development, and societal well-being. Yet commercialization and technology-based start-ups can be challenging in an academic environment due to varying reward structures, organizational structures, organizational cultures and a lack of entrepreneurial education to bridge the gap between basic science and commercialization. The Babson L-SPRINT program will develop, recruit participants for, and deliver a specialized entrepreneurial education curriculum highlighting Babson’s signature Entrepreneurial Thought & Action® offering coupled with customized health and biomedical entrepreneurship content on addressing market segmentation and uncertainty, commercializing emerging technologies, scaling for growth, and interactive biomedical community building experiences.